Precision Lung Cancer Survivorship Care Intervention: A Randomized Controlled Trial Serving Rural Survivors and Communities

PROJECT SUMMARY
Among the devastating illnesses impacting rural America, few exact the physical, social, psychological, and
economic toll of lung cancer. Lung cancer is the leading cause of cancer death in rural America, and the levy is
particularly acute in Kentucky – a state that not only leads the nation in lung cancer incidence and mortality but
is a global epicenter of lung cancer. Despite the prevailing nihilism regarding lung cancer care, lung cancer
survivors are living longer. Innovations in prevention, early detection, and treatment, have created substantial
optimism and opportunities for long-term lung cancer survivorship. These dramatic changes in the lung cancer
care landscape have invigorated the need for quality lung cancer survivorship interventions. The overarching
goal of the Kentucky LEADS Collaborative Lung Cancer Survivorship Care program is to reduce the
burden of lung cancer by offering an innovative survivorship care approach that improves lung cancer
quality of life, overcomes lung cancer stigma, and helps survivors engage with care. Using a novel
precision survivorship approach and developed in collaboration with rural community stakeholders, the
program's foundation incorporates principles of patient-centered care, shared decision making, and
motivational interviewing to build survivor engagement. A large acceptability and feasibility trial conducted in
collaboration with nine lung cancer care facilities in Kentucky with lung cancer survivors (N=140) demonstrated
the acceptability of the intervention among survivors, caregivers, and lung cancer care clinicians. The study
also revealed the feasibility of conducting the proposed study methods in rural cancer care facilities. The
proposed project continues this program of research by conducting a two-group parallel randomized clinical
trial comparing the impact of the Kentucky LEADS Collaborative Lung Cancer Survivorship Care program
(KLCLCSC) among lung cancer survivors (N=300) against an enhanced usual care condition
(bibliotherapy+assessment) on quality of life outcomes. Rural-residing lung cancer survivors will be recruited
from ten oncology care facilities throughout Kentucky. The project's first aim compares the efficacy of the
interventions with regard to lung cancer quality of life among survivors as measured by the FACT-L and other
rigorous assessments of patient engagement, symptom burden, psychosocial well-being, and behavior
change. The project's second aim evaluates the moderating impact of including caregivers as intervention
partners on survivor quality of life outcomes. A third aim evaluates the cost-effectiveness of the KLCLCSC
intervention in comparison to the enhanced usual care condition. Based on highly encouraging pilot data
collected in collaboration with oncology care programs in Kentucky, this research holds credible potential to
establish a new paradigm for addressing the challenges associated with lung cancer and for delivering quality
survivorship care to rural-residing, economically distressed lung cancer survivors.

Public health relevance
PROJECT NARRATIVE Lung cancer is the leading cause of cancer mortality in the nation, and the burden of the illness is disproportionally experienced by individuals residing in rural areas and experiencing economic challenges. Recent advances in early detection and treatment of lung cancer foretell significant reductions in lung cancer mortality, engendering a need for research efforts to inform lung cancer survivorship care guidelines. This research outlines a randomized clinical trial of a precision lung cancer survivorship care intervention aimed at improving quality of life among rural lung cancer survivors within socioeconomically distressed areas in the US.